ETHNICITY AND IMMUNOSUPPRESSION

To determine if ethnic differences exist in pharmacokinetic and pharmacodynamic responses to immunosuppressive drugs. We have seen some differences inter- and intra-individual. Therefore, we had to request additional subjects to show statisical differences.